Diversity Supplement: Targeting chemoresistant prostate cancer with novel EED inhibitors

This Diversity Supplement will train Ms. Skylar Grayson, a highly qualified African American researcher, in
cancer research and prepare her for a doctoral program in biological sciences, clinical pharmacology, or
toxicology. Ms. Grayson will participate in the Specific Aims 2 and 3 as outlined in the parent grant, specifically,
evaluating the in vitro and in vivo activities of new EED inhibitors against chemoresistant PCa in preclinical
models and determining the drug-like properties and toxicology of lead compounds. We will provide a
candidate-specific training environment to maximize Ms. Grayson’s potential as a graduate student in
pharmacology or toxicology.

Public health relevance
This Diversity Supplement project supports the Candidate, Ms. Skylar Grayson, to conduct laboratory research for the funded parent R01 grant. The two-year research and training project will allow Ms. Grayson to gain valuable and relevant experiences in pharmacology and toxicology, which will help her be competitive when applying for a doctoral program in biological sciences, clinical pharmacology, or toxicology graduate programs.